Heat and Acute Kidney Injury: A Detailed Assessment using Electronic Medical Records and High-Resolution Exposure Modeling

PROJECT SUMMARY
Acute kidney injury (AKI) is a sudden decrease of kidney function that is almost always reversible. While
reversible, AKI is serious and often requires hospitalization. The economic burden is also substantial, estimated
at $5-24 billion annually in the USA. Although AKI can arise within already-hospitalized patients (“hospital-
acquired AKI”), an unknown proportion of AKI initiates outside of the hospital (“community-acquired AKI”). One
potential contributor to the incidence of community-acquired AKI is exposure to high ambient temperatures,
which is thought to impact kidneys largely through volume depletion. Motivated by increasing concerns about
climate change, population-level studies using administrative health data have consistently reported positive
associations between outdoor heat (high temperatures and heat waves) and emergency department (ED) visits
and hospitalizations for AKI. A key limitation of existing studies is the identification of AKI cases through
International Classification of Disease (ICD) discharge diagnosis coding. Code-classified AKI, while specific, is
not a sensitive marker of AKI; it misses a high percentage of total cases. Moreover, it does not distinguish
community-acquired from hospital-acquired AKI, cannot assess AKI severity, and does not provide information
on patient context. In addition to these limitations, the majority of population-level studies have relied on spatially
crude measures of temperature (e.g., from one or a few monitoring sites) that do not fully capture important
urban heat dynamics. As a whole, the misclassification in both AKI outcome and heat exposure contribute to a
lack of understanding of the true effect of outdoor heat on AKI. This project is motivated by the need for (1)
improved outcome assessment, (2) improved exposure assessment, and (3) the identification of heat-vulnerable
populations that can be protected via targeted interventions. To address these needs, we will analyze a highly
detailed clinical database of over 1.5 million electronic medical records in Atlanta, Georgia for 2013-2021 linked
to a high-resolution, state-of-the-art exposure product that will developed as part of this project. For
ascertainment of AKI cases, we will consider ICD diagnosis codes - reflecting what has been used in the heat-
AKI literature – as well as via assessment of a KDIGO (Kidney Disease Improving Global Initiative)-based serum
creatine (SCr) definition comparing ED ‘first-measured’ SCr to baseline values. The KDIGO definition will enable
a specific assessment of community-acquired AKI and severity (i.e., stage). In Aim 1, we will develop of a rich
database of ED visits, heat exposure metrics at patient residential address, and individual- and area-level
sociodemographic and health risk factors. In Aims 2 and 3, we will estimate associations of short-term outdoor
heat exposure and AKI, and will identify individual- and area-level risk factors that increase vulnerability to
outdoor heat-related AKI. This work will fill major gaps in the epidemiology of outdoor heat and AKI that will
ultimately support targeted outreach and education activities, guide improvements in clinical care, and provide
inputs for quantitative risk assessment and economic evaluation of heat-health impacts.

Public health relevance
NARRATIVE Heat exposure is a contributor to dehydration and therefore can affect kidney function. We propose to investigate the relationship between heat (outdoor high temperatures and heat waves) and presentations of acute kidney injury (AKI) at emergency departments in Atlanta, GA. With a focus on improved AKI case ascertainment, heat exposure assessment, and identification of heat-vulnerable populations, this work will fill major gaps in the epidemiology of heat and AKI that will ultimately support public health prevention and clinical case management.